NRSA Training Core

PROJECT ABSTRACT
Training Core
The LAUNCH Program Training Core will produce scientists who are well trained and able to compete
successfully for research funding and who are also able to think creatively and collaboratively
to generate impactful and innovative science. We have designed a comprehensive training program that
includes didactic and experiential learning in scientific inquiry which will be paired with extensive
mentoring, career development support and networking opportunities. Our Training Core will (1) provide a
strong foundation in content and methodology of the trainee’s chosen research area (i.e. basic, translational, or
clinical science); (2) generate highly interactive opportunities to learn from peers and faculty the language and
culture of multidisciplinary team science; (3) support and nurture strong relationships between trainees and
their mentoring committee to maximize the trainee’s research productivity as well as professional development;
(4) facilitate access to the LAUNCH training faculty who represent a network of outstanding scientists,
teachers, and mentors who are collectively tackling problems related to nephrology, urology, or
hematology; and (5) expose trainees to career development skills that will help provide a springboard for
scholars to advance from their training towards independent scientific careers. We aim to produce a cadre of
outstanding junior investigators who are innovators and the future leaders in the fields of nephrology, nonmalignant urology, and non-malignant hematology. Following the completion of our LAUNCH Program, we
expect that our alumni will be uniquely poised to develop new and creative approaches to the diagnosis,
prevention, and treatment of diseases within KUH disciplines and to thrive in research careers. The LAUNCH
Training Core will be led by Dr. Chi-yuan Hsu (nephrology), Dr. Mark Walters (pediatric hematology), and Dr.
Philip Beachy (urology), all of whom have extensive mentorship experience and a successful track record in
research training and scientific inquiry.